A Prospective Cohort Study of Patients with Non-Small Cell Lung Cancer and Multiple Myeloma to Assess the Benefits and Harms Related to Cannabis Use During Treatment

With the majority of Americans supporting legalization of medical cannabis, the number of patients asking their
clinicians about medical cannabis has also significantly increased. Many clinicians, however, feel that they
have inadequate knowledge about the efficacy, side effects, and abuse potential of medical cannabis. One
national survey of oncologists reported that only 30% felt sufficiently informed to make recommendations
regarding medical cannabis use, even though 80% regularly conducted conversations about medical cannabis
with patients. A study from Washington State found 21% of patients with cancer surveyed had used cannabis
in the past month. Despite the common belief among many patients that herbal therapies such as cannabis are
inherently safe, the evidence is growing that greater caution is needed with cannabis as it may have potential
direct side effects and may lead to interactions between herbs such as cannabis and medications. Thus, an
important knowledge gap exists regarding the use of cannabis by patients with cancer during active cancer
treatment, and this prospective cohort study is proposed to address these questions. This study aims to assess
the prevalence and patterns of cannabis use among patients with cancers of the lung and multiple myeloma
during active treatment as well as inquire about the communication patterns regarding cannabis use with their
treating medical team. In order to reduce the complex variables that exist between the types of cancers and
treatments, we will study two unique cancer populations – non-small cell lung cancer (NSCLC) and multiple
myeloma (MM), with each cohort studied separately. These patients provide a homogenous population of
patients with cancer that have generally standardized treatment regimens. Cancer patients currently receive
platinum-based chemotherapy either before (neoadjuvant) or after (adjuvant) receiving surgery together with a
PD-1 inhibitor (a type of immune checkpoint inhibitor (ICI), ex. nivolumab). Newly diagnosed MM patients are
recommended to receive induction therapy with lenalidomide, bortezomib, and dexamethasone (RVd) for three
to six months followed by an autologous stem cell transplant (ASCT). These two cohorts provide unique
opportunities to study the impact of cannabis use in both a solid tumor and hematologic cancer during
chemotherapy. For the NSCLC cohort, we will also assess the effect of cannabis on immunotherapy efficacy.
For the MM cohort, we will assess the effects of cannabis during ASCT. Concurrently, we will survey oncology
healthcare providers about their perceptions, education, and practice patterns regarding cannabis use by
patients. Data collection will include information about all the medications including prescription, over-the-
counter, herbs, and supplements in order to assess for the prevalence of potential medication interactions with
cannabis. We hypothesize that a substantial proportion of patients receiving cancer treatment are using
cannabis (~20%) and that there are different patterns of cannabis related benefits and harms based on cancer
type and treatment as well as patient demographics including socioeconomic factors.

Public health relevance
Project Narrative A significant proportion of patients with cancer are using medical cannabis, and limited data exists regarding the potential benefits and harms of this use during active treatment. This prospective study will provide information regarding cannabis use by patients with lung cancer and multiple myeloma including assessing the benefits and harms between cannabis users and non-users.